Drug Action, Metabolism and Kinetics Training Grant

Project Summary
This pre-doctoral Pharmacological Sciences Training Program (PSTP) is a cross-disciplinary program that
represents a merger of research training opportunities in the Schools of Medicine (Pharmacology) and
Pharmacy (Medicinal Chemistry and Pharmaceutics) at the University of Washington. The rationale for this
program is that it is essential for providing in-depth training in several inter-related disciplines that are central to
current and future research related to the discovery, validation and development of new drug targets and new
chemical entities that will improve global health. This focus distinguishes training provided by the PSTP from
other pre-doctoral training grants available at UW. The primary objective of the PSTP is to develop scientists,
equipped with the necessary background in the biological and chemical sciences and training in the application
of modern tools of research and instrumental techniques, to undertake and direct fundamental research related
to drug action, metabolism and pharmacokinetics. Trainees follow tracks that emphasize training in four
broadly defined areas: (I) cellular and molecular pharmacology, (II) structure and drug/vaccine design, (III) drug
metabolism, (IV) pharmacokinetics, drug transport and delivery, which exist in the departments of
Pharmacology, Medicinal Chemistry and Pharmaceutics. Didactic components involve individualized, highly
multidisciplinary programs of coursework and seminars that are centered on the biological and chemical
sciences. Additional program elements include a PSTP-specific journal club, a 'career' day that brings
scientists from varied 'nontraditional careers' to speak with trainees, industry mentors and internships, and
recently added emphasis on rigor and reproducibility. The program brings together 34 well-funded faculty
members whose research emphasizes training in mechanisms and regulation of cell signaling,
neuropharmacology, structural analysis of pharmacologically relevant protein-ligand interactions, mechanistic
and bio- analytical aspects of drug metabolism and toxicology, pharmacogenetics, pharmacokinetics/dynamics
and drug transporter function and regulation. Under-represented and disadvantaged students, who are actively
recruited through a number of faculty activities, currently represent ~33% of the training cohort. In this
competitive renewal of the Pharmacological Sciences National Research Service Award program, support is
requested for 13 pre-doctoral trainees per year. The selection of trainees will be on a competitive basis from
the pool of students in years 1-3, who are committed to research in one of the aforementioned areas.

Public health relevance
Project Narrative This predoctoral training program provides technical training in research related to discovery and characterization of new therapeutic agents, including scientific rigor, leadership, and communication skills. Interdisciplinary training at multiple levels ensures that trainees can contribute to and lead future efforts aimed to optimize health through the improvement of existing medications or discovery of new ones. !